The Role of Neutrophils in Cystic Fibrosis Pathogenesis

ABSTRACT
Cystic fibrosis (CF) is a life-threatening genetic disorder, caused by mutations in the gene that encodes cystic
fibrosis transmembrane-conductance regulator (CFTR), a cAMP-activated chloride channel. This disease affects
multiple organ systems, including the lung, intestine and other epithelium-lined organs. The most destructive
pathologies are characterized to be chronic bacterial infection, persistent neutrophilic inflammation and
mucopurulent duct obstruction. As bacterial infection and neutrophilic inflammation are highly related to innate
immune cells, neutrophils should be a major player in the disease pathogenesis. However, the prevailing belief
holds that CF is a disorder resulting from the malfunction of epithelial cells, and all the clinical consequences
stem from this epithelial anomaly. As a result, the significance of neutrophils in the disease process has been
underappreciated. Our previous research discovered that CFTR is pre-made and pre-stored in the secretory
vesicles within mature neutrophils, and is critically needed for transporting chloride to the phagosomes to
produce hypochlorous acid (HOCl or bleach) for neutrophil anti-microbial function. However, it is unknown when
the CFTR protein is made during neutrophil differentiation. Moreover, when infection occurs in the lung,
neutrophils are mobilized from the circulation to the lung lumen. Under this condition, how neutrophils acquire
chloride to support their essential host defense function has never been elucidated. Furthermore, lung health is
collectively protected by multiple types of cells, including permanent lung-resident cells, such as pulmonary
epithelial cells and tissue macrophages, and transient lung-recruited immune cells, notably neutrophils and
monocytes/macrophages. The exact contribution of CF neutrophils to the overall CF infection and inflammation
in this system is undetermined. To fill these gaps in knowledge, we have laid out a detailed plan in this application
to address the following outstanding questions: 1) how CFTR is expressed during neutrophil steady-state or
infection-precipitated emergency granulopoiesis, 2) whether chloride acquisition by neutrophils on an epithelial
surface is limited by epithelial CFTR function, and 3) to what extent the CF neutrophil defect contributes to the
CF infection and inflammation. This research will produce unprecedented data to refine the current paradigm of
CF disease. New insights will be provided to establish the critical role of neutrophils in the disease pathogenesis.
Novel therapeutic targets may be revealed for developing innovative and effective treatments to combat
established infection and inflammation in CF.

Public health relevance
PROJECT NARRATIVE Patients with cystic fibrosis (CF) suffer from chronic infection and persistent inflammation in their lungs and intestines. The underlying mechanism has not been clearly elucidated. The current application has laid out a detailed plan to determine if neutrophils, the predominant inflammatory cell, play any significant role in the disease onset and development, which will produce unprecedented data to better understand the disease and to better design therapies for effective treatments.